Structural studies of the full-length nucleocapsid protein of SARS-CoV-2

Project Summary
The coronavirus disease 2019 (COVID-19) is caused by severe acute respiratory syndrome coronavirus 2
(SARS-CoV-2). The nucleocapsid (N) protein of SARS-CoV-2 plays several functionally critical roles in the life
cycle of the virus, similar to those in other coronaviruses. It assembles with the genomic RNA into an RNA-
protein complex, which is packaged into virions. The protein also forms a replication-transcriptional complex with
the RNA synthesis machinery to create replicating organelles for efficient transcription and replication. It protects
viral double-stranded RNA (dsRNA), which would otherwise be degraded by the RNA interference (RNAi)-based
antiviral immune defense mechanism in the host cells. N protein adopts a modular architecture with two well-
folded domains, including N-terminal domain (NTD) and C-terminal domain (CTD), which are flanked by three
intrinsically disordered regions. Crystal structures of the NTD and CTD have been determined, but high-
resolution information of the full-length N protein, in particular, in complex with RNA is still lacking. We
hypothesize that intrinsically disordered regions of the N protein from SARS-CoV-2 adopt defined
structures when bound to RNA that are critical for viral assembly and replication. In this project, we plan
to determine the high-resolution structure of the full-length N protein in complex with the viral RNA by cryogenic
electron microscopy (cryo-EM). The goal is to visualize detailed structural features of the full-length N protein in
the context of RNA to advance our understanding of its function and to inform development of intervention
strategies. Our specific aim is to obtain a high-resolution structure of intact SARS-CoV-2 N protein in complex of
RNA.

Public health relevance
Project Narrative The nucleocapsid (N) protein of SARS-CoV-2 plays several functionally critical roles in the life cycle of the virus. This proposal aims to provide an atomic picture of the full-length SARS-CoV-2 N protein in complex with the viral RNA to advance our understanding of the molecular mechanism of viral assembly and to facilitate development of intervention strategies.